DYSREGULATED NFKB PATHWAY SIGNALING IN MYELOPROLIFERATIVE NEOPLASMS

7. Project Summary/Abstract
Myeloproliferative neoplasms (MPNs) are chronic blood disorders that that can cause severe symptoms and
early death. New treatments have become available recently that help ameliorate symptoms, but they do not
reliably slow or halt disease progression. We seek to better understand what drives disease development and
progression in MPNs, so that we can develop better therapies for patients with these diseases.
Our preliminary data indicates that a signaling pathway called the NFkB pathway is abnormally activated in
MPNs. We hypothesize that this pathway contributes to the development and progression of MPNs. Therefore,
we have proposed a combination of mouse and human studies to determine how the NFkB pathway
contributes to MPN pathogenesis, and to evaluate whether inhibition of NFkB signaling may have potential
therapeutic benefits for MPN patients.

Public health relevance
8. Project Narrative Myeloproliferative neoplasms (MPNs) are clonal hematologic malignancies that cause significant morbidity and have the propensity to transform to acute leukemia. Current treatment options for MPNs are limited. The studies proposed here will provide deeper insights in the pathogenesis of MPNs, and potentially lead to the development of more effective therapies for patients with MPNs.